Developmental trajectories of reinforcer pathology and childhood obesity

ABSTRACT
The percentage of children with obesity increases throughout development. Obesity results from a
positive energy balance, which suggests the energy balance gap increases as children age. Reward systems
that drive the motivation to eat or be physically active, conceptualized as food and activity reinforcement,
mature throughout development, potentially exerting a greater influence on adolescents than younger
children's decision-making. Executive functions that allow youth to focus on long-term goals rather than
immediate gratification are not fully developed until early adulthood. Reinforcer pathology theory considers the
balance between the reinforcing value of food and physical activity and the need for immediate versus delayed
gratification (as measured by delay discounting). The differential trajectories of reinforcement and delay
discounting may be essential to understanding the increase in obesity from childhood through adolescence.
Reinforcer pathology theory can be used to understand how changes in food and activity reinforcement drive
eating and activity in the context of a developing executive function system that regulates these processes.
Food is a powerful, primary reinforcer that activates brain reward pathways and motivates people to
eat. Physical activity is also a powerful reinforcer that motivates people to be active. Obesogenic environments
contribute to food and activity reinforcement, through excess caloric intake and a sedentary lifestyle, which
may have opposing developmental trajectories, as energy intake and food reinforcement may increase while
physical activity decreases. Decreases in physical activity begin around ages 9-10 and continue throughout
adolescence, which suggests a reduction in the motivation to be active. Delay discounting, which can regulate
the need for immediate gratification, improves from childhood to adolescence through adulthood. This study
will fill a gap in assessing developmental trajectories of food and activity reinforcement and delay discounting
in children from 9-16 years-of-age, which captures a developmental period with an increase in obesity
prevalence. The study uses an innovative cohort sequential design to assess developmental trajectories of the
reinforcing value of food and activity, delay discounting, dietary intake and physical activity, zBMI and body fat
(Aim 1); assess the relationships between developmental trajectories of food and activity reinforcement, delay
discounting, dietary intake and physical activity with the trajectories of zBMI and body fat (Aim 2); and test
environmental and socioeconomic factors that can influence the developmental trajectories of zBMI and body
fat through trajectories of food and activity reinforcement, dietary intake and physical activity, and delay
discounting (Aim 3). This study will be the first to use reinforcer pathology theory to assess how developmental
trajectories of food and activity reinforcement, delay discounting and eating and physical activity relate to the
development of obesity throughout childhood and adolescence. This information can guide pediatric obesity
interventions tailored to developmental stages and behavioral phenotypes.

Public health relevance
NARRATIVE The prevalence of obesity increases from childhood through adolescence, and research is needed to understand factors that relate to excess energy intake relative to expenditure, resulting in positive energy balance and weight gain. Reinforcer pathology provides a theoretical approach to understanding the balance of the motivation to eat or be active with the need for immediate or delayed gratification, each of which changes throughout development. This grant will assess for the first time how trajectories of food and activity reinforcement and delay discounting in combination with eating and activity patterns contribute to the trajectories of weight gain throughout development, which can guide pediatric obesity interventions tailored to different developmental stages and behavioral phenotypes.